Patient Oriented Research and Mentoring in Multidisciplinary Chronic Pain Treatments

Clinician-scientists provide distinct and valuable perspectives on patient-oriented research (POR). Unfortunately, the number of new clinician-scientists has steadily declined over the past few decades. Mentorship is a critical means of developing an effective pipeline of clinical research faculty. Thus, there is an urgent need to develop and sustain midcareer clinician-scientists to continue their POR programs as well as dedicate time and effort to mentoring the next generation of POR clinician scientists. Dr. Kratz is a midcareer clinician-scientist in the Department of Physical Medicine and Rehabilitation at the University of Michigan. She is a licensed clinical psychologist with clinical and research expertise in mind-body, complementary, and integrative treatments of hard-to-manage symptoms, such as chronic pain and fatigue. The goal with this K24 application is to achieve 25% protected time for the applicant to continue mentoring trainees in POR and to grow her current research program in new directions to expand opportunities to mentor in POR focused on complementary and integrative medicine. The candidate has demonstrated significant commitment to and abilities in mentoring trainees at all career stages and will continue to benefit from the robust academic environment at the University of Michigan that provides stellar research infrastructure and a large pool of mentees. During the funding period, further development of the applicant will include: 1) Improvement in mentorship and leadership skills in POR; 2) Building skills and collaborations in acupressure for management of pain and other symptoms; and 3) Development of skills and collaboration in use of just-in-time adaptive interventions to deliver mind/body/behavioral symptom self-management programs. These skillsets will be achieved through a combination of workshops, meetings, courses, and collaboration with technical experts and mentors. In addition, these skillsets will grow through continued mentorship of trainees within currently funded POR and through expansion into new complementary and integrative approaches for pain management through the K24 mechanism. Research opportunities include: work that examines the effects of cannabinoids on sleep and pain in multiple sclerosis (Project 1); A multi-stage project to develop and then pilot test an acceptance-based eHealth program for chronic pain management in spinal cord injury (Project 2); A study to develop and assess the usability of relaxing and stimulating self-acupressure therapies for symptom management in multiple sclerosis (Project 3) and; A new study that builds on the candidate’s previous ambulatory research characterizing momentary dynamic associations between pain and functioning by expanding to develop just-in-time adaptive interventions to promote symptom self-management (Project 4). Completion of this award will result in successful mentoring of current and future mentees in POR and enlarge the POR program of the applicant to ensure continued mentoring opportunities into the future.

Public health relevance
The goals of this K24 application are to support Dr. Kratz’s continued development as a mentor and to grow her successful research training program for Patient-Oriented Research (POR) through an interdisciplinary translational research program focusing on complementary and integrative approaches for pain management. The awarding of the K24 Mid-Career Investigator Award would ensure that the candidate has protected time to mentor current and future mentees and securing funding to support and further expand her research program, which serves the main context for training POR clinician scientists.